CYTOKINES, MICROGLIA AND VIRAL PRODUCTS IN THE CNS PATHOLOGY OF HIV INFECTION

The devastating effects of the HIV virus on the CNS range from slowly deteriorating function such as a mild concentration loss to complete dementia. The etiology of this deterioration is not understood, particularly since the HIV virus does not infect neurons. Our hypothesis is that soluble mediators that are elicited from the interaction of the HIV virus with the host exert toxic effects on neurons compromising their function. This hypothesis has been tested in an animal model system where host antiviral molecules are expressed in the ocular compartment of the brain, a situation that leads to neuronal loss and inflammation. In the current funding period we will study the factors that mediate the deterioration of CNS functions in AIDS dementia, as understood through our animal models. We will focus on three critical aspects of cytokine mediated CNS alterations: inflammation, immune responsiveness, and regulation of neuronal apoptotic cell death. We hypothesize that each of these three processes contribute to the observed CNS functional deterioration in human HIV infection. We will determine what molecules mediate the infiltration of myelomonocytic cells into the CNS, and try to block this infiltration. We will define the role of the cytokine induced immune response to viral antigens in CNS dysfunction by deriving a new model more closely resembling human CNS AIDS. This will be accomplished by targeting the HIV NEF protein to the myelomonocytic compartment and inducing an immune response to this protein. Lastly, we will test the possible contribution of the protoncogene bcl-2 to neuronal dysfunction or to possible therapeutic intervention. This gene product has ben shown to allow neuronal survival from virus-induced cell death. The studies in the proposal should increase our knowledge of factors that cause CNS dysfunction in AIDS dementia, allowing strategies for therapeutic intervention including blocking of myelomonocytic cell entry into the brain, tolerization of deleterious immunogenic epitopes and the delivery or regulation of proto-oncogene expression in neurons to mediate their survival and long term function.